IAA with UNITED STATES DEPT OF ENERGY

The proposed study is a planned retrospective analysis of stored serum, tissue biopsies, and other biological samples to identify linkages between pre-diagnostic biological markers, DNA mutational profiles, and environmental exposures. The subject population will be DoD members selected by investigators at NIEHS. Up to four serial serum samples will be requisitioned from the Department of Defense Serum Repository (DoDSR) and sent to PNNL for global discovery mass spectrometry for unbiased biomarker discovery. The overall objective is the discovery of proteomic markers for environmental exposures and, when possible, the correlation of these discoveries with clinical data to drive future studies aimed at risk reduction or mitigation. This study will involve the following five tasks: 1. Process serum samples using immunoaffinity depletion columns if required; 2. Digest the samples with trypsin and clean up using solid-phase extraction (SPE) columns; 3. Peptide Fractionation; 4. LC-MS analysis of the peptide samples using the TMT labelling method; 5. Data analysis.